Adapting and implementing the I-HoME intervention in caregivers of patients with ADRD

PROJECT SUMMARY
Overview: The proposal aims to adapt and pilot test the Improving Home hospice Management of End-of-life
issues through technology (I-HoME) intervention for caregivers of ADRD patients with advanced illness. I-HoME
is a caregiver-directed intervention that supplements existing care with video visits and education provided by a
palliative trained nurse practitioner.
Background: The number of patients with Alzheimer's Disease and Related Dementias (ADRD) who need and/or
receive palliative care has increased steadily over the past few decades. Yet, research focused on developing
and testing services and models to best meet the palliative care needs of ADRD patients and their caregivers
remains modest. As a result, multiple organizations have called for research to improve palliative care in affected
patients and their caregivers.
Research plan: Aim 1 of the proposal is to adapt the I-HoME intervention for caregivers of ADRD patients with
advanced illness by leveraging stakeholder input through interviews with providers (n=15) and caregivers (n=15)
of ADRD patients. Using an iterative user-centered design approach, the data collected will inform adaption of
the I-HoME manual, protocol, and data collection instruments to address the care needs of patients with ADRD
and their caregivers. Aim 2 of the proposal is to pilot test the adapted I-HoME intervention with family caregivers
(n=15) of ADRD patients with advanced illness. Data will be collected regarding intervention feasibility and
acceptability. Secondary measures will consist of ADRD symptom assessment tools, caregiver burden, caregiver
anxiety and depression scores, and caregiver satisfaction.
The proposal has the potential to lead to advances in introducing new models of palliative care delivery to support
caregivers of ADRD patients with advanced illness around symptom management and care issues.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because there is an increasing need for palliative care services to improve care outcomes for patients with Alzheimer's Disease and Related Dementias (ADRD) and their caregivers. This project proposes to adapt the Improving Home hospice Management of End of life issues through technology (I-HoME) intervention for caregivers of ADRD patients with advanced illness. The intervention supplements existing care with video visits and education provided by a palliative trained nurse practitioner to address symptom management and care needs.